REGULATORY MECHANISMS IN HUMAN NATURAL CYTOTOXICITY

This research program will explore the following hypotheses: (1) natural cell-mediated cytotoxicity (NCMC) is a complex phenomenon that is mediated by more than one mononuclear cell subset and is modulated by cellular interaction, and (2) NCMC is regulated by interferon and other soluble factors through differential effects on the various effector cell types to produce the resultant natural cytotoxic effects. In order to test these hypotheses, we intend: (1) to identify and isolate the cell types involved in NCMC using physical and biological criteria; (2) to define the roles and interactions of these lymphocyte subpopulations in the regulation of NCMC; and (3) to elucidate the roles of soluble mediators including interferon in the regulation and modulation of NCMC. Two cytotoxicity tests, chromium release and single cell assays, are used to study NCMC. Lymphocytes are separated by density and size as well as by methods using cell surface markers. Subpopulations thus obtained are mixed in different combinations to define interactions in cytotoxic reactions. Lymphocyte subsets are treated with interferon and other factors, and mixture experiments will be performed on treated and untreated combinations to understand the control mechanisms such factors exert on NCMC. Two populatlons of NCMC effectors that can be isolated by density have been identified. The LGL population sediments toward the top of the Percoll density gradient. A heavier population is identified by a smaller increase in activity at the bottom of the gradient. These populations may differ in their recycling abilities. NCMC effector cells self-regulate by producing interferon. Accessory and helper cells are being investigated. Monocytes can augment as well as depress NCMC. The augmentation is demonstrable following direct mixture of monocytes with null cells in the NK assay, and following preincubation of the cells prior to testing of the re-isolated null cells for NCMC. The augmentation is dependent upon monocyte concentration and length of the pre-incubation period, and is associated with an increased number of target binding cells with lytic activity. Purified LGL appear less susceptible to the effect of monocytes than the less pure null cell population. (IS)